Complete human parent-of-origin genome: functional signatures and developmental determinants of disease.

SUMMARY
There are over 10 million children in the US suffering from rare disease, most of these diseases are genetic and
require DNA sequencing for diagnosis, however even with contemporary clinical sequencing and knowledge of
thousands of diseases most patients remain undiagnosed. One area of understudied rare disease is imprinting
diseases with only dozen diseases known to date, where developmentally the parental copies (maternal and
paternal) of genes are regulated differentially and the DNA variants can be harmful only if inherited from either
mother or father. This regulatory difference can be read by sequencing DNA CpG-methylation. The Genomic
Medicine Center (GMC) at Children’s Mercy Kansas City (CMKC) has spearheaded systematic generation of full
genomes by long-read 5-base sequencing (5mC-HiFi-GS) that collects CpG-methylation data in parallel with all
genetic variation and applied it to thousands of rare disease families, including families suffering from unusual
pregnancy losses building a comprehensive resource of long-read, parentally resolved genomes across different
human cell types and developmental stages. Using this 5mC-HiFi-GS resource we have found hundreds of
genes and thousands CpG dinucleotides not previously known to be imprinted to show unequivocal evidence of
parent-of-origin (PofO). These observations are harnessed here to characterize new diseases and
developmental processes governed by parental differences in gene regulation. Specifically, we will develop a
comprehensive and enhanced map of human imprinted genes or “imprintome” in the 5mC-HiFi-GS resources,
which includes optimized technology, scale and sample procurement for sensitively and specifically detecting
PofO dependent DNA in human genome. The PofO regions in genome are then characterized by single nuclei
epigenome analyses and long-read RNA sequencing to link each novel imprinted sequence to its target gene.
Finally, in three rare disease cohorts we will look for new variants and diseases caused by perturbation in PofO
regulated genes and DNA. In parallel, we will study the overall developmental influences of these gene regions
beyond specific rare diseases using common variation in growth (e.g. height) using our patient cohorts and then
validate in population samples (UK Biobank). Through the extensive new information on human genome
regulation differentially between maternal and paternal copies combined with detailed family-based cohorts we
will uncover new determinants of development and disease in this understudied layer of human genome
variation.

Public health relevance
NARRATIVE Only a few dozen genomic imprinting loci are well validated in humans where a handful of these cause rare congenital disorders if the imprinting signature is disturbed. We hypothesize that human imprinting catalog is incomplete and may lead to misassignment of true rare developmental disease alleles.